Understanding Clinician-Parent Interaction to Reduce Disparities and Improve Quality of Pediatric Surgical Care

PROJECT SUMMARY
Racial/ethnic minority children who undergo surgery have worse clinical outcomes compared to white or more
affluent peers. Although clinical and environmental determinants contribute to these disparities, evidence
suggests that these disparities may rise in part from racial/ethnic differences in relationships and communication
between surgical clinicians and parents, which are a potentially remediable source of healthcare inequities. The
importance of physician-family communication is particularly significant in the milieu of pediatric surgical care,
where patients and parents may perceive surgeons as intimidating, paternalistic, or dismissive relative to other
specialists. The goal of our project is to develop an innovative, valid, and scalable measurement and analytic
approaches for better understanding of patient-physician interactions. Findings will inform development of
interventions to improve communication and thereby enhance quality of equity of pediatric surgical care delivery.
This proposal focuses on two innovative features of communication: linguistic style matching (LSM) and linguistic
accommodation. LSM is the tendency of participants to use a common vocabulary and speech structure, while
linguistic accommodation is the process by which participants in a conversation adjust their language according
to the speech style of the other participant. Both LSM and linguistic accommodation have been rarely explored
and are potential mechanisms by which less social/cultural distance can result in higher quality relationships and
outcomes. Using a mixed-methods sequential explanatory study design, we apply computerized text analysis
tools and subsequent thematic content analysis of clinician-parent interactions during pediatric surgical
consultations to (1) Elucidate dimensions of parent and clinician linguistic style and generate novel measures of
LSM and linguistic accommodation in pediatric surgical care, (2) Evaluate the convergent and predictive validity
of LSM and linguistic accommodation, and (3) Explore dialogue examples and themes from visits where clinician
linguistic style dimensions are associated with higher and lower parent ratings of surgical clinicians.
We apply quantitative and qualitative methodology to wholly understand the significance and potential
contribution of LSM and linguistic accommodation to bridging social distance in communication. We propose
generating communication measures through automated text analysis versus traditional manual coding. Theis
innovative approach can elucidate mechanisms by which surgical clinicians can communicate more effectively
and reduce racial/ethnic disparities in surgical outcomes, provide initial validity evidence for novel communication
analytic methods, expand the cost-effectiveness and scale of communication analysis studies of physician-
parent interaction, and inform development of real-time feedback systems for surgical clinicians to improve their
interactions over time. Because each surgical clinician sees many patients, small improvements in clinicians’
relationship and communication skills can have a large effect on improving quality and equity in patient outcomes.

Public health relevance
PROJECT NARRATIVE Racial/ethnic minority children who undergo surgery have worse outcomes compared to white or more affluent peers. Positive relationships and communication between the family and surgeon are essential to make high quality treatment decisions and overcome racial/ethnic disparities in clinical outcomes. This study explores generation of automated methods of analyzing parent-clinician communication, with the goal of identifying effective communication behaviors that can be easily taught to pediatric surgical clinicians.